Exploring the Role of Long Noncoding RNAs in Germinal Center B cells

The germinal center (GC) response is the basis for effective vaccination, enabling both affinity maturation and
memory development. In an iterative process, higher affinity GC B cells (GCBC) are progressively selected. At
the same time, a small fraction of GCBC exit cell cycle and differentiate into long-lived progeny—either memory
B cells (MBC) or plasma cells (LLPC). These processes are controlled by integrating different signals from the
environment (e.g. from Ag, T cell help) that in turn are transmitted via signaling networks to the cytoplasm and
nucleus, where cellular behavior and responses are determined. Our lab has studied these processes at multiple
levels, including GC surface phenotypes, reprogramming of signaling, and gene expression and epigenetic
alterations that are GC-specific. The work of many labs has revealed complex transcription factor (TF) networks
that control GC affinity selection and differentiation. While signals that control and induce TFs are clearly
important, they are unlikely to be the complete story. RNA-mediated control is one layer that has received
considerably less attention. Long non-coding RNAs (lncRNAs)—which share many characteristics of protein-
coding mRNAs such as splicing, 5’ cap, and 3’ polyadenylation—have emerged as a broad, complex class of
regulatory molecules responsible for modulating key aspects of cell biology. In addition to regulating the
processes of transcription and translation, lncRNAs have been implicated in epigenetic regulation of the
chromosomal landscape, as well as a host of other diverse cellular processes, including molecular scaffolding
and sequestration. The human genome has more lncRNAs than protein-coding RNAs; yet, the function of most
of these is unknown. Intriguingly, many lncRNAs are only expressed in one or a few tissues. Recently, a few
studies have described lncRNAs expressed in the B cell lineage in human, including in GCBC. However, relative
to their abundant representation in the genome, lncRNA encoding genes have been investigated at only a
cursory level, and there are no functional data on lncRNA in GCBC. This R21 is a request for funding of our lab’s
initial work to investigate this novel arena as part of our efforts to understand GC function and gene regulatory
networks. We have used deep RNA-seq and a stringent pipeline to identify putative GC-specific lncRNAs,
measured their expression via Q-PCR, then cloned and sequenced them to determine their structure. We focus
in this proposal on using genetic and functional approaches to understand the function of three of the most
interesting lncRNAs (“GCLnc1, 2 and 3”). For GCLnc1 we have already generated a germline deletion and an
overexpression system: both have exciting preliminary phenotypes. Our Aims are: 1) To fully characterize B cell
responses of the GCLnc1 KO mouse; 2) Generate transcriptional STOP null alleles of GCLnc1, 2 and 3 and
determine initial phenotypes in primary B cell responses; and 3) Overexpress each GCLncRNA in GCBC using
a novel cell transfer system developed in our lab and determine the functional effects in vivo. We will do this in
collaboration with Dr. Maninjay Atianand, a lncRNA expert who works on lncRNA function in macrophages.

Public health relevance
Germinal Centers (GC) are sites in the body where long-lived immune responses occur that help prevent new infections after vaccination or recovery from an initial infection. GCs continue for weeks to months executing a Darwinian selection process to select the very best responses to be stored for the future. Long noncoding RNAs (lncRNAs) are a new category of genetic information that plays many biological functions but does not make protein. There are tens of thousands of them in the human genome but most of their functiosn are unknown. In this grant we propose to discover new lncRNAs that are expressed in GCs and use genetic means to determine how they control the function and efficiency of the GC process.